Sexual dimorphic circuits in photoperiodic encoding and photic processing

PROJECT SUMMARY/ABSTRACT
Light regulates neurological function through circuits that remain poorly defined, and there remains a significant
unmet need in understanding photic plasticity in the brain of both sexes. For example, seasonal changes in
day length (i.e., photoperiod) modulate sleep, attention, appetite, metabolism, mood, and immune function
occur in a large number of people, with up to 80% being women. The suprachiasmatic nucleus (SCN) drives
circadian and photoperiodic responses to light, but there is a large gap in our understanding of sex differences
in SCN photic and photoperiodic processing. Our preliminary data indicate that circadian and photoperiodic
responses differ by sex, with females display larger behavioral responses to light mediated by divergent SCN
circuits. Based on these data, we propose the central hypothesis that photic processing differs between males
and females because the retina-SCN circuit is sexual dimorphic. We will test that biological sex influences
cellular responses to light (Aim1), photoperiodic responses to day length (Aim2), and neural adaptations in
SCN circuits (Aim3). These studies will benefit from the collective expertise of this collaborative research team,
which specializes in retinal physiology, SCN network properties, cellular imaging, and computational analyses.
Independent of sex differences, successful completion of these studies will provide novel insights into neural
mechanisms of photic processing and photoperiodic encoding to advance understanding in both sexes.
Further, this work is expected to provide information that will be critical to better understanding diseases
incurred by other forms of light-induced disruption (e.g., shiftwork, jetlag).

Public health relevance
Seasonal changes in day length cause physiological and psychiatric disturbances that relapse every year. There is a sex difference in the occurrence of seasonal disorders, with women at least twice as likely as men to be adversely affected. Understanding the basis of seasonal disease and why women are affected disproportionately is an area of critical unmet need. These studies will generate novel insights into how day length alters the function of neural circuits in both sexes, which will comprise the basic foundations for identifying novel ways to combat seasonal pathology.